Systems Technology Core

PROJECT SUMMARY/ABSTRACT – SYSTEMS TECHNOLOGY CORE
The Systems Technology Core (STC) provides members of the Center for Human Health and the
Environment (CHHE) with the necessary technical expertise, state-of-the-art instrumentation,
and novel analytical approaches in a single umbrella core (under a single Director) to address a
broad range of scientific questions related to the impact of the environment on human health.
Specifically, the STC facilitates the use of advanced “omics” technologies - (1) genomics,
transcriptomics and epigenomics, (2) discovery-based and targeted proteomics, (3) broad
spectrum and targeted metabolomics, including environmental toxicants (e.g. emerging PFAS,
PFOA), and (4) metallomics, including metal speciation. Importantly, the STC engages
investigators at all points of the data life cycle, providing input on project conception and
experimental design, performing data collection and analysis, and coordinating with the CHHE
Environmental Data Sciences Group to ensure proper data curation and deposition in
appropriate repositories. The novel integration of “Navigators”, PhD level experts budgeted to
assist CHHE members with study design and method development, within STC allows
researchers to rapidly identify appropriate techniques or approaches to interrogate their
research questions and to readily integrate findings across multiple technology platforms,
often in concert with other CHHE and University core facilities. Overall, the STC empowers
investigators to make advanced quantitative measurements to better understand how human
health is impacted by key environmental risk factors.